Severe neonatal hyperbilirubinemia (SNH) and the expression of UDP-glucuronosyltransferase 1A1 (UGT1A1) play key roles in the development of necrotizing enterocolitis (NEC)

ABSTRACT
Severe neonatal hyperbilirubinemia (SNH) and necrotizing enterocolitis (NEC) are the most common causes
of morbidity in newborns worldwide, with both symptoms being linked to human breast milk (HBM). Enteral
formula feeding is a direct biomarker for the induction of NEC in preterm newborns, while HBM protects
against NEC. In newborns, HBM suppresses UDP-glucuronosyltransferase (UGT) 1A1 expression, the only
transferase capable of conjugating bilirubin, thus contributing to the development of hyperbilirubinemia.
Humanized UGT1 (hUGT1) mice that express the human UGT1A1 gene mimic what is observed in
humans with neonatal hUGT1 mice developing SNH. As an animal model to examine the mechanisms that
lead to regulation of the UGT1A1 gene, we have documented that the UGT1A1 gene is repressed in liver
tissue, which plays a key role in total serum bilirubin (TSB) accumulation. While approximately 10% of the
neonatal hUGT1 mice develop Kernicterus Spectrum Disorder (KSD), which is lethal, most of the newborns
are healthy, have normal reproductive cycles, and represent an excellent model to study the underlying
mechanisms linking UGT1A1 expression to SNH. New findings from our laboratory have demonstrated that
the delay in intestinal UGT1A1 expression is controlled specifically by the nuclear receptor transcriptional
corepressor protein, NCoR1. When NCoR1 is rendered non-functional through genetic knockout experiments
in the intestines, neonatal TSB levels are normal and intestinal UGT1A1 is dramatically induced, resulting from
intestinal epithelial cell (IEC) maturation. The delay in intestinal UGT1A1 in neonatal hUGT1 mice is a direct
result of breast milk, since formula feeding leads to significant induction of UGT1A1. HBM plays a key role
in the development of SNH by blocking bilirubin metabolism while simultaneously protecting newborns against
NEC. Thus, we hypothesize that the underlying mechanisms leading to SNH are also linked to the underlying
mechanisms that regulate NEC. This may not be a coincidence but crucially important to understand, since
bilirubin is a potent antioxidant that could combat oxidative stress induced intestinal inflammation, which
leads to NEC. Thus, the focus of our efforts will determine if complimentary cellular mechanisms are tied to
the development of both SNH and NEC. The major focus areas, based upon current publications and
preliminary findings, will be to tie the role of microflora, TRL4 signaling, HBM oligosaccharides, and
neonatal IEC maturation, with the control and regulation of SNH and NEC. The experiments outlined
are anticipated to lead to a greater understanding of these syndromes, made available using novel mouse
models and advanced technology that will allow us to connect the early biological events after birth leading
to the developmental control of SNH with those same processes that will be tied to the onset of NEC. Because
there does not exist effective therapeutic interventions for the treatment of either SNH or NEC, the long-term
goal of this work and the unraveling of the mechanisms leading to these syndromes will be to use this
information to improve the development of effective therapy.

Public health relevance
Narrative Two of the more serious clinical syndromes that afflict newborn children are severe neonatal hyperbilirubinemia (SNH), which can develop both in preterm and term newborns and lead to severe CNS toxicity, and necrotizing enterocolitis (NEC), which is mainly restricted to preterm newborns. We will argue and present new findings that the development of SNH and the events leading to protection against NEC are regulated through similar mechanisms, leading us to suggest that the onset of SNH, which displays potent antioxidant properties, is not a random event in preterm newborns but may have evolved as a protective event to combat inflammatory diseases. Using novel animal models that express the human UGT1 locus and the UGT1A1 gene and develop SNH during the neonatal period, experiments are outlined to examine the interrelationships in the mechanisms that control the onset of SNH and NEC with the intention of exploiting these findings to identify potential therapeutic targets to treat NEC.